Leveraging natural and engineered genetic barcodes from single cell RNA sequencing to investigate cellular evolution, clonal expansion, and associations between cellular genotypes and phenotypes

PROJECT SUMMARY
Cells are constantly altering their states, whether due to physiological stress or exogenous forces. Clonal
expansion is a well-defined process that contributes to this alteration and indiscriminately occurs in all types of
tissue throughout the body, irrespective of the malignant or disease potential of that tissue. Any mutations or
epigenetic changes that one sustains over the course of a lifetime are thus at risk of being clonally expanded
and ultimately propagated within cell lineages15,16. However, questions still remain as to why some of these
expansions result in cancer while others remain benign and as to how the specific steps that individual cells
take genetically and transcriptionally to become pathogenic and ultimately evolve and embody different
phenotypic states. These phenotypes include expression cell state, activity of mutational processes (e.g.,
endogenous APOBEC DNA/RNA deamination mutagenesis), and propensity to persist under treatment.
Understanding how cells change their states provides insight into how to control cell fate, which can have
ramifications on our understanding of cell plasticity, development, evolution, and disease progression.
Computational analysis of single-cell genomes offers an opportunity to provide insight into these questions in
biology, but there is a gap in the current ability of existing methods to extract confident variant calls from single-
cell RNA sequencing data. Research to date has relied on laborious, inefficient methods limited to mostly cell
lines or inherently noisy single-cell DNA data to attempt to understand this interplay between cell lineages,
acquired mutations and genomic features (i.e., creating artificially-induced genetic barcodes or using natural
DNA mutations)17-20. This project focuses on the development of a more robust genomic tool for building these
single cell phylogenies and associating them with cellular phenotypes by leveraging the cell’s transcriptional
machinery with full length scRNA-seq. The specific aims of this project can be summarized as follows:
1. Utilize scRNA-seq and CRISPR-based lineage tracing data to reconstruct phylogenies and identify
specific genomic associations at the single cell level.
2. Investigate the role mutational processes have on clonal expansion and disease progression across
tissues at single-cell resolution.
To achieve these project goals as well as my own career objectives to becoming a successful independent
genomic scientist, my training plan includes training in machine learning, phylogenetics, and mechanistic
biology, as well as further training in scientific communication skills such as manuscript writing and grant
writing. My excellent research environment includes the Broad Institute of MIT and Harvard, where my home
lab of Dr. Gad Getz is located. This is a world-class institution for genomics research rich in people resources
and all other necessary resources needed to perform my proposed research.

Public health relevance
PROJECT NARRATIVE It is well established that cells accrue genomic mutations throughout a lifetime, most of which are benign and simply serve as genomic markers, while others drive clonal expansion that can lead to tumorigenesis. In both cancer genomics and developmental biology, tracking cell states over time, whether it be hematopoietic lineages or subclones within a tumor microenvironment, can provide insight into the specific steps that cells take to alter their states. Mutations identified in individual cells, coupled with phenotypic information such as expression, provides intrinsic barcodes to characterize cells in fine detail, thus enabling the construction of a cellular map that could allow us to alter cell states in ways that are beneficial for human health.